CAPTURING MEDICAL MISINFORMATION IN SOCIAL MEDIA USING AN ADVANCED AI SOLUTION SET

To develop digital tools to identify and combat malicious digital bots that spread misinformation about infectious disease treatments and vaccines, including COVID-19 vaccines.